Integrative Systems Biology Core

PROJECT SUMMARY/ABSTRACT
The Integrative Systems Biology Core will interact with all investigators to develop and apply appropriate analysis
methods and designs to most efficiently achieve project goals. We will ensure that the experimental data is
analyzed appropriately to test the hypotheses relevant to each project. In addition, the Integrative Systems
Biology Core will provide infrastructure and oversight for secure management of all study data, working closely
with the Bioreagents & Resource Core to facilitate accuracy and completeness of datasets for all projects and
investigators. Our specific aims are: (1) To integrate cutting-edge analytic approaches in the design, analysis,
and interpretation of experimental studies across projects in our program; and (2) To provide secure and
accessible database systems and computational infrastructure to facilitate reliable and reproducible analyses
conducted by all program investigators. The Integrative Systems Biology Core leverages faculty and resources
in the Case Comprehensive Cancer Center, Case Western Reserve University School of Medicine and the
Duke Molecular Physiology Institute. Dr. Thomas LaFramboise will direct the Core, with Dr. Simon Gregory
as co-director. The Integrative Systems Biology Core will serve as a centralized resource for all personnel,
including the leaders of the three research projects and the Bioreagents & Resource Core. The Core will assist
investigators with all facets of design, computational analysis and interpretation. Established as well as novel
tailored analytic methods are available to promote scientific discovery for investigators within the Core. Core
personnel will interact with investigators in all stages of research, from data management, data analysis,
interpretation, writing scientific manuscripts and grants, to dissemination of results. The Core will also
facilitate access to secure and accessible database systems, facilitating analysis, discovery and
collaboration. The Core will assist all investigators with development, management and reliability of their project
data and will also integrate information across databases, such as incorporating clinical and experimental data
with biospecimen data as provided by the Bioreagents & Resource Core. The Integrative Systems Biology Core
will provide a natural foundation for cross-pollination among the projects and Cores, the Core personnel
collaborating with all project investigators and Core directors.

Public health relevance
PROJECT NARRATIVE The Integrative Systems Biology Core will interact with all investigators to develop and apply appropriate analysis methods to ensure that the experimental data is analyzed appropriately to test the hypotheses relevant to each project.